PHASE I TRIAL OF CT-1501R AND HIGH DOSE IL-2 IN RENAL CANCER OR MELANOMA

CT-1501R, a metabolite of pentoxifylline, may be capable of ameliorating IL-2 induced toxicity. This is a Phase I multi-centered, open-label, plasma concentration-controlled escalation study of CT-1501R in patients undergoing IL-2 treatment for advanced renal cell cancer or metastatic melanoma.